Dysregulated Complement Pathway in Macrophage Reprogramming and Progression of HCC in MASH

ABSTRACT
Hepatocellular carcinoma (HCC), a deadly form of liver cancer, is becoming increasingly common in patients
with metabolic dysfunction-associated steatohepatitis (MASH), a rapidly growing cause of chronic liver
disease. Macrophages are believed to play a key role in promoting HCC in MASH. Interestingly, the
complement pathway, which regulates macrophage function, seems to worsen MASH instead of resolving it.
This paradoxical behavior of the complement pathway might be a critical link between pro-tumor macrophage
reprogramming in MASH and the development of HCC. Our prior research demonstrates that pro-tumor
macrophage reprogramming fosters an immune-evasive microenvironment in HCC. Building on this, we
conducted spatial analysis of human MASH-HCC, uncovering three critical findings: a unique immune-evasive
spatial organization characterized by pro-tumor-macrophage neighborhoods and CD8T cell exhaustion, the
activation of the complement pathway through the C3-C3AR1 axis, and the downregulation of SERPING1, a
crucial complement pathway inhibitor, in MASH-HCC. Based on these findings, we hypothesize that the loss
of SERPING1 leads to complement-mediated pro-tumor macrophage reprogramming in MASH, thereby
promoting HCC. We are using three innovative methods to test this hypothesis. First, we will manipulate
SERPING1 in patient-derived 3D tumor models composed of cancer cells and macrophages, using a
microfluidics system. Second, we will target C3-mediated complement activation in immunocompetent mouse
models of MASH-HCC which recapitulate major components of MASH, including metabolic syndrome,
steatohepatitis, fibrosis, and HCC. Third, we will employ CODEX, a 53-plex single-cell spatial technology, to
visualize and quantify complement pathway activation in specific tumor and macrophage compartments in
human HCC. To test our central hypothesis, we have conceived three interconnected, yet independent, specific
aims. In aim 1 we will investigate if SERPING1 is necessary for pro-tumor macrophage reprogramming in
MASH-HCC. We will perform in vitro and in vivo studies using 3D tumoroids and orthotopic implantation of
HCC cells with varying SERPING1 levels in diet-induced MASH models, and examine tumor progression and
macrophage reprogramming. In aim 2 we will assess the efficacy of C3ar1 inhibition, alone or combined with
anti-Pdl1, in a mouse model of MASH-HCC, using MRI and mass cytometry for tumor and immune response
analysis. In aim 3 we will quantify complement pathway expression in HCC tissue and peripheral blood, using
a retrospective-prospective study design to correlate complement levels with disease progression and clinical
outcomes in patients with MASH and HCC. Overall, this research targets a pivotal gap in understanding
immune-evasion of HCC arising in MASH, aiming to identify novel treatment strategies. Successful completion
of this study will lead to novel use of therapies targeting the complement pathway in MASH-HCC, with the goal
to improve long-term survival of patients with this deadly cancer.

Public health relevance
PROJECT NARRATIVE The incidence of liver cancer related to a form of fatty liver disease called metabolic-dysfunction-associated steatohepatitis (MASH) is rapidly increasing both in the US and globally. This project will study immune mechanisms of liver cancer in MASH using patient-derived 3D tumoroids, robust preclinical models and single cell spatial imaging, to identify how the complement pathway reprograms macrophages and promotes cancer. The study is critical for public health, as it has the potential to lead to development of biomarkers and novel targeted therapies for liver cancer in MASH.